Ultrashort Echo Time Magnetic Resonance Imaging of Hemophilic Arthropathy

PROJECT SUMMARY/ABSTRACT
Hemophilia is an x-linked bleeding disorder characterized by deficiencies in clotting factor VIII or IX. Patients
suffer from frequent joint bleeding, which may lead to debilitating hemophilic arthropathy (HA). Both
symptomatic and silent bleeds, as well as unnoticed microhemorrhages, generate hemosiderin deposits, the
primary etiology of joint degeneration in HA. Non-invasive imaging of both hemosiderin and the subsequent
damage it causes to cartilage and subchondral bone is important for optimizing costly prophylactic treatment
plans and monitoring disease progression. While magnetic resonance imaging (MRI) is the gold standard for
evaluation of HA, it has significant limitations including imprecise, only semi-quantitative evaluation of
hemosiderin deposition, and an inability to detect both early iron deposition and degeneration in cartilage and
subchondral bone. Ultrashort echo time (UTE) MRI sequences, with TEs ~100 times shorter than those of
clinical sequences, can overcome these limitations. Using targeted UTE sequences, fast transverse relaxation
signals from hemosiderin and the osteochondral junction (OCJ) can be directly detected with high contrast.
This study aims to develop a complete package of UTE MRI techniques for evaluation of HA, including 1)
accurate quantification of hemosiderin through volumetric mapping of T1, T2*, and susceptibility; 2) assessment
of early cartilage damage by monitoring proteoglycan and collagen; and 3) evaluation of the OCJ, and aims to
apply this package in cross-sectional and longitudinal studies of three groups of HA patients (mild, moderate,
and severe), as well as an age-matched control group. In Aim 1 we will further optimize the speed, contrast,
resolution, and accuracy of a series of 3D UTE MRI techniques for morphological and quantitative evaluation
of hemosiderin in synovium, and for assessment of articular cartilage health and OCJ changes using a clinical
3T MR scanner. In Aim 2 we will evaluate the optimized 3D UTE and clinical MRI sequences for assessment
of hemosiderin, cartilage, and the OCJ in ex vivo tissues from hemophilia patients following total knee
arthroplasty (n=10) and from normal cadaveric human knee joints (n=10). We will compare UTE-based
morphological and quantitative measures (tissue magnetic susceptibility, T1, T2*, fat fraction, adiabatic-T1ρ,
magnetization transfer ratio, macromolecular fraction) with clinical MRI evaluation of hemosiderin, cartilage,
and the OCJ, and we will correlate UTE and clinical MRI measures with histopathology, biochemistry, and
biomechanics. In Aim 3 we will apply the optimized 3D UTE and clinical MRI techniques to evaluate outcome
of prophylaxis in three groups of hemophilia patients with mild (n=20), moderate (n=20), and severe (n=20) HA
at two time points (baseline and 12 months), and a group of age-matched healthy volunteers (n=20) once.
Cross-sectional and longitudinal UTE and clinical MRI measures will be correlated with Hemophilia Joint
Health Scores (HJHSs), Pettersson radiograph scores, and self-reported outcomes. We expect that UTE
sequences will be more sensitive to early changes in hemophiliac joints than clinical MRI.

Public health relevance
PROJECT NARRATIVE The goal of this study is to optimize and validate a series of 3D Ultrashort Echo Time (UTE) MRI sequences with TEs ~100 times shorter than those of clinical sequences for comprehensive evaluation of joints with hemophilic arthropathy (HA) through assessment of hemosiderin, cartilage, and the osteochondral junction. We will first optimize a series of UTE MRI techniques in phantoms and human patellar samples, then validate them in ex vivo tissues from hemophilia patients following total knee arthroplasty (n=10) and from normal cadaveric human knee joints (n=10). Finally, we will apply the optimized 3D UTE and clinical MRI techniques in three groups of hemophilia patients with mild (n=20), moderate (n=20), and severe (n=20) HA at two time points (baseline and 12 months) and in one group of age-matched healthy volunteers (n=20) once, to evaluate the outcomes of prophylaxis by correlating cross-sectional and longitudinal UTE and clinical MRI measures with Hemophilia Joint Health Scores (HJHSs), Pettersson radiograph scores, and other self-reported outcomes.